Improve Lung Regeneration Through Targeting Tuft Cells Following Viral Infection

ABSTRACT
Seasonal influenza and the current COVID-19 pandemic cause serious health and financial burdens. Severe viral infection
leads to acute lung injury, inflammation and contributes to tissue remodeling and fibrosis. Intriguingly, clusters of ectopic
basal cells (also known as pod cells) are present in the peripheral lungs during acute infection and remodeling phases. Initial
studies indicated that these cells were able to generate type I and II alveolar epithelial cells (AECs). Nevertheless,
subsequent lineage tracing studies revealed that pod cells had minimal if any contribution to alveolar regeneration.
Moreover, our preliminary data suggest that pod cells give rise to goblet cells, resulting in mucous metaplasia accompanied
by the presence of chemosensory tuft cells (also known as brush cells). Significantly, genetic ablation of tuft cells promotes
the differentiation of pod cells into AECs. Our further analyses revealed that tuft cells express the Notch ligand Jag2,
whereas pod cells express Notch receptors with prominent Notch activation. Consistently, Notch inhibition led to reduced
mucous metaplasia and improved alveolar regeneration. We therefore hypothesize that tuft cells promote mucous
metaplasia of pod cells and impede alveolar regeneration via paracrine JAG2/Notch activation upon viral infection.
Two specific aims were devised to test the hypothesis. Aim1: To address the molecular mechanisms by which tuft cells
promote mucous metaplasia following viral infection. Aim2: To promote the differentiation of pod cells into AECs through
targeting JAG2 in tuft cells. In this aim we will combine a novel COVID-19 mouse model and pod cell organoids
established from COVID-19 patient lungs to test the efficacy of a JAG/Notch decoy in promoting alveolar regeneration.
Together this proposal will not only elucidate the disease mechanisms impairing lung regeneration post viral infection, but
also offer new therapeutic approaches to treat lungs infected by influenza and coronavirus.

Public health relevance
Project Narrative Annual flu and recent COVID-19 infection cause extensive destruction of alveolus structures, and inappropriate regeneration leads to prolonged inflammation and pulmonary diseases including fibrosis. Here, we use a combination of mouse models, organoid culture, single-cell analysis and pharmaceutical reagents to address how the chemosensory tuft cells are involved in lung regeneration following viral infection. The proposal will provide novel insights into fundamental mechanisms with broad scientific and clinical implications.